Role of KCNQ2 Channels in Control of Breathing

SUMMARY
DevelopmaenndetpaillepntciecphalaospsaotchiwyaittKehCdNQc2hannhealsbseepnrimalriinlktyeod
loss-of-KfCuNnQcm2tuitoantiHoonwse.vaenri,ncreansuimnbgoefrrecurKrCeNnQtg2ain-of-fun
vari(ain.tRes2.0C,1)havbeeeindentPiaftiiewedin.thshKeCNQR221oc mutatdiiosnpsleavyemryeoclonu
andearplryofohuynpdoventdiuletaorteidounccehdemoreCfulrerxe.mnetclhya,nibsywmhsicKhCNQ2
channceolnsttrhdoerlitvobereaatrhueencleTahrer.etrotrnaupcelz(eoRuiTsdiNsa)nimporrteasnptirat
centneeru;rointshriesgifounncatsiroenspircahteomroyrecbeyprteogruslatinginrespotnose
breathin
changientsisCsOu2.eChemosenRsTiNnteiuvreaornaesctivbayatniendcreianCsO2/eH+,whereagaasin­
of-funKctniqmo2untatmiioghnhytperpoRlTaNnreiuzreaonmdsakiemtordeiffitcoruelstptoonCdO2/H+.
Indeweodr,fkrotmhpearegnrtasnhtowtehdeaxtpresosftihroeencurKrcennqmt2utatKiconnRq221ocinRTN
neurbolnusntthevedentirleastpoortnyoCsOe2.Excitwienagllsfyoo,utnhdaKtcnqc2hanancetliivnRiTtNy
neuroinsrsegulbaytaed+-Hmyo-Incoos!irtaonls(pHoMrItwTeh)ricihmpomrytos-intososiutpoplort
producotfpihoonsphatid4y,l5i-nboissipth(ooPls2I)pP,ahnaatlelosatcetriivocafKtconrqc2hannHeMlIsT.
expresisntihoRenTNregiiosrnestroinclttyoecdhemosennseiutrioTvnhese.refwoehryep,othtehsaitze
HMIiTsrequfiorKrecdnqc2hanancetliivnRiTtNnyeuroInnpsa.rtiwceuplraorp,tohsHae+t-depenmdyeon­t
inostirtaonlsipnotRroTtNneurobnyHsMIwTiilnlcrePaI2sPleevaenldsactiKvcantqec2hannteollismit
CO2/H+-stimualcattiaevdsiwteyla,lstomaintnaeiunrmaoldulabtynieounrotrantshmasititgttneharrlsough
Gq-courpelceedpatnodPrIs2PhydrolTyhsutishs,oe.bjecotftihvaiepspliciasttodieotnertmhieenxetetnot
whiKcchnqc2hannaenlHdsMIiTntetrocaocnttRrToNclhemorecuenpdtneiorornmcaolndiatniwdohnesther
HMIcTabnetargettoiemdprborveatihnmiincgtehaetxprKecsnsRq22o1.cThethrSepeecAiifmioscfthis
projaerce1t:)detertmhieenxetetnowthiHcMhIiTnfluKecnncqec2shanrnegluloaftcihoenmosensit
RTNneuro2n)dse;tercmoinnteriboufKtcinoqcn2hsannaenldHsMIiTnteratcoRtTiNocnhsemorecep
netweoxrckitaabnid3l)tioetsyt;abHlMiIsiThnRTNneuroansastherapteaurtfgioeKcrtcnqa2ssociat
breatahbinnogrmaTlhiertaiteisof.notarhlrieesseairstchhabtyundersthaonwHdMiInrTgegulKactneqs2
chanancetliivnRiTtNyneurownecsa,lnaayfoundaftodireovnelotprienagtmfeornretsspirpartoobrlyems
associwaitKehcdnqm2utations.

Public health relevance
Project Narrative In the past several years, important progress has been made in identifying genes implicated in neurodevelopmental disorders. It is now recognized that KCNQ2 loss and gain of function mutations lead to developmental epileptic encephalopathy that might also include respiratory dysfunction and severe central hypoventilation syndrome. Therefore, the goal of this application is to understand the essential role of KCNQ2 in control of breathing that may explain both the origins and developmental progression of symptoms, as well as to propose strategies for effective therapeutic interventions.